AUTOMATED CTF DETERMINATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The three-dimensional reconstruction of macromolecules from two-dimensional single-particle electron images requires determination and correction of the contrast transfer function (CTF) and the envelope function. A computational algorithm based on constrained nonlinear optimization is developed to estimate the essential parameters in CTF and envelope function model simultaneously and automatically.